Overall: Resource-based Center for Musculoskeletal Disorders Research

? DESCRIPTION (provided by applicant): The Penn Center for Musculoskeletal Disorders (PCMD) will continue to enhance the research productivity of, and provide critical resources and programs to, investigators to address multidisciplinary research strategies for musculoskeletal problems. The overall goal of this Center is to promote cooperative interactions among investigators, accelerate and enrich the effectiveness and efficiency of ongoing research, foster new collaborations and new research, and ultimately, translate our research efforts into better and new therapies for musculoskeletal disorders. The central theme of the Center will continue to be Musculoskeletal Tissue Injury and Repair. This theme is broad (as it includes all musculoskeletal tissue types, such as bone, cartilage, disc, ligament, meniscus, muscle, and tendon), focused (as takes advantage of commonalities in approaches across tissue types), and clinically significant (as it fosters development of assays, procedures and knowledge in pre- clinical animal and human models of translational relevance). It is important to note that our PCMD is not a bone center nor is it a muscle center. Rather, it is truly a musculoskeletal center and has emerged as the recognized home for musculoskeletal research across the Penn campus and as a technical and intellectual resource for the broader Philadelphia musculoskeletal research community. Thus, the primary overall aims of this Center are to enhance and advance the research productivity of investigators in musculoskeletal tissue injury and repair by: 1) Providing innovation within critical resource core facilities in areas that cross disciplines, length scales, and hierarchies. These core facilities are µCT Imaging, Biomechanics, and Histology, 2) Developing a pilot and feasibility grant program for investigators, with direct mentorship, whereby new approaches, ideas, and collaborations can be developed prior to seeking extramural funding, and 3) Developing educational and research enrichment programs spanning tissue types, research approaches, and paradigms, through which members can learn from national leaders and from each other. High quality musculoskeletal research is currently being conducted by many groups at Penn. While many bring sophisticated approaches to bear on musculoskeletal problems, few groups have the required expertise and facilities to perform high quality and specialized assays in their own labs. Furthermore, most investigators are not aware of approaches utilized, and results obtained, in other tissues that may have direct relevance on their research questions. Ultimately, close cooperation, communication, and collaboration among researchers across musculoskeletal tissue types and from a wide variety of disciplines will significantly enhance the research of our members. The Center will provide opportunities to integrate multi-disciplinary techniques to determine mechanisms for tissue function, injury, degeneration, repair, and regeneration, with the ultimate goal of advancing the diagnosis, treatment, and prevention of diseases and injuries of the musculoskeletal system.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Penn Center for Musculoskeletal Disorders will continue to enhance the research productivity of, and provide critical resources and programs to, investigators to address multidisciplinary research strategies for musculoskeletal problems. The overall goal of this Center is to promote cooperative interactions among investigators, accelerate and enrich the effectiveness and efficiency of ongoing research, foster new collaborations and new research, and ultimately, translate our research efforts into better and new therapies for musculoskeletal disorders within the theme of "Musculoskeletal Tissue Injury and Repair".